Neural mechanisms of perceptual abnormalities and their malleability in bodydysmorphic disorder

Abstract
Individuals with body dysmorphic disorder (BDD) misperceive specific aspects of their appearance to be
conspicuously flawed or defective, despite these being unnoticeable or appearing miniscule to others. With
convictions of disfigurement and ugliness, they typically have poor insight or delusional beliefs, obsessive
thoughts and compulsive behaviors, anxiety, and depression. These result in significant difficulties in
functioning, depression, suicide attempts (25%), and psychiatric hospitalization (50%). Despite this, relatively
few studies of the neurobiology, and few treatment studies, have been conducted. This underscores a critical
need for research to identify novel targets for intervention based on a comprehensive understanding of the
pathophysiological mechanisms. While preoccupation with misperceived appearance features of the face and
head are common in BDD, additional concerns about the body (from the neck down) are also highly prevalent.
Yet, misperceptions of the body are often of a different nature than face concerns; these typically pertain to the
size and shape of body parts rather than specific details. Common examples are that one’s thighs are too large
or small, or that one’s chest is too large or small. Face concerns, on the other hand, typically involve
misperception of small details, e.g. skin blemishes. Size/shape misperceptions may have different causes
related to brain functioning and behaviors than those involving details. Further, distortions of one’s internal self-
body image (one’s imagined body in the absence of a stimuli such as a mirror) may contribute to appearance
preoccupations. We plan to uncover mechanisms of body misperception in the context of self-body
representations by determining own-body size estimation accuracy while also measuring brain function and
eye behaviors. The additional experimental procedures will use a digital avatar tool, Somatomap 3D, to
quantify body size estimation, while simultaneously obtaining fMRI and eye-tracking data. With data collected
in the overall study, the results promise to provide valuable information to help develop new targeted
behavioral, perceptual, and/or brain stimulation treatments to address body image distortion that involve
appearance aspects of the body or face.

Public health relevance
PROJECT NARRATIVE A core symptom of body dysmorphic disorder (BDD) is perceptual distortions for appearance, which contributes to poor insight and delusionality, limits engagement in treatment, and puts individuals at risk for relapse. Results from this revised study, adding a body processing experiment to the existing face processing experiments, will provide a more comprehensive understanding of factors accounting for a broad range of appearance concerns in BDD. This will lay the groundwork for next-step translational perceptual retraining approaches to address face and body perceptual distortions.